Methods to build and annotate tissue atlases using spatial genomic data

Project Summary/Abstract
Single-cell spatial technologies hold the promise of understanding spatially-resolved cell state and discovering
how cells interact locally to create complex tissues and organisms. In contrast to bulk sequencing or disassoci-
ated cells, with spatial genomic data we may catalog the diversity of cells and cellular environments in healthy
and diseased tissues, characterize cell types and healthy variation in cell state and cellular collectives, and study
the effects of local environment on cell state. However, spatial genomics technologies also pose important
challenges to analytic methods, specifically, they have small fields-of-view, they are hard to normalize and align
across samples, and there are limited genomic markers assayed.
This proposal aims to construct queryable, multiscale, reference-free, annotated 3D tissue atlases to study how
cells organize into tissues using 2D slices from spatial genomics technologies such as MERFISH, Slide-seqV2,
MIBI, or even histology images. These 3D tissue atlases will allow us to align spatial genomics data and
disassociated single-cell data to a 3D coordinate system. The atlases may be queried at specific 3D coordinates,
within regions of interest, or for specific cell types for expected values of genomic markers. The atlases will be
annotated with landmarks noting regions of interest, with genomic markers to identify those regions.
Our objectives are to develop methods that build 3D tissue atlases from 2D spatial genomics samples with-out
reference coordinate systems, to validate these methods by building and annotating 3D atlases for mouse heart,
mouse brain, and human glioblastoma tumors using existing data, and, to identify the local influence of each
aligned cell in the atlases. We will rely heavily on our expertise in Gaussian processes to infer smooth functions
across spatial coordinates. The resulting atlases are able to capture cell-type specific relationships, spatial
differential expression, regions of interest, and landmarks, allow integration of multimodal data and robust
imputation of missing data, and are flexible with respect to biological scale, resolution, and field-of-view.
To accomplish these goals, in aim one, we will develop methods to build and annotate referencefree, queryable,
multiscale 3D tissue atlases from 2D spatial genomics samples. In aim two, for validation, we will build atlases
with existing data for developing mouse heart, adult mouse brain, and human glioblastoma tumors. We will
develop an experimental design module to allow users to robustly design their own tissue atlas with min-imal
spatial genomics samples, and create a software package including a graphical user interface to visualize,
explore, and analyze atlases. In aim three, we will build methods to identify the regions of local influence of each
cell and cell type in an atlas. All methods will be available in GitHub through a user-friendly package. The three
atlases will be publicly available to allow data alignment and searches or queries. We hope to create methods
that allow single labs on limited budgets to build and study 3D tissue atlases for their tissue of interest.

Public health relevance
Project Narrative Spatially-resolved single-cell sequencing data have the potential to explain how cells communicate and interact, how cell state is impacted by its local environment, how specific dysregulation might eventually lead to disease, and how targeted interventions might modify cell state to treat disease. Our goal in this proposal is to develop spatial statistical methods to ensure that this potential is achieved; in particular, our proposed methods will i) create robust software to build multiscale, three-dimensional, queryable, cell-type aware, and reference- free atlases of tissues and organs from a handful of two-dimensional spatial genomics samples, ii) annotate these atlases by finding spatially-resolved expression patterns within and across cell types, and iii) quantify the influence of each aligned cell in the atlas on their local environment. In this proposal, we are motivated by existing data from mouse and human heart, mouse and human brain, and human brain tumors, where both common and rare cell types, expression gradients critical to tissue function, and essential cell-cell interactions are just beginning to be discovered and understood.